Investigating the Role of HDL-Associated Serum Amyloid A in Sepsis-Induced Acute Lung Injury and Mortality

Abstract/Project Summary
Sepsis is a life-threatening condition caused by a dysregulated immune response to infection. The prognosis for
sepsis remains poor, with mortality rates exceeding 30%, due to a lack of effective treatment options. Thus far,
despite over 100 randomized controlled trials, no treatments have shown a survival benefit, and no specific
therapies are available for sepsis. One reason for the failed trials may be the lack of understanding of the
pathways involved in the resolution of the immune response in sepsis. We have identified Serum Amyloid A
(SAA), a family of acute phase proteins, as required for sepsis survival. Our preliminary and published data show
that using two well-established sepsis mouse models, SAA-deficient (TKO) mice had exacerbated lung injury
and increased mortality compared to wild-type (WT) mice in sepsis. Adenovirus-mediated overexpression of
SAA not only increased survival in TKO mice but also in WT mice. Lungs of TKO mice had significantly increased
neutrophils, myeloperoxidase (MPO) activity, and markers of leukocyte infiltration compared to WT mice. SAA
and SAA-bound to high-density lipoprotein (SAA-HDL) decreased neutrophil transmigration through laminin-
coated membranes in vitro. SAA in circulation is associated with HDL. Several clinical and animal studies indicate
that decreasing HDL levels is a risk factor for sepsis, and raising HDL may be an effective therapy. SAA is the
predominant apoprotein on HDL during acute inflammation. Based on these findings, we propose 2 specific aims
with the central hypothesis that systemic SAA-HDL resolves sepsis-induced lung injury and mortality by
regulating neutrophil infiltration into the injured lung: (Aim 1) We will test the hypothesis that SAA mediates the
resolution of sepsis by impeding neutrophil accumulation in injured lungs and we will identify molecular players
involved in SAA-neutrophil interaction. (Aim 2) We will demonstrate that SAA imparts HDL’s sepsis protective
effects and decreasing systemic SAA-HDL negatively impacts sepsis outcomes. This study is significant and
innovative since it will refute the old paradigm that SAA promotes inflammation in an acute inflammatory setting
and will establish for the first time that SAA mediates HDL’s protective effects in sepsis by resolving sepsis-
induced inflammation. The study is clinically relevant because many generalized anti-inflammatory therapies
may decrease circulating SAA levels and thus inadverdently negatively impact sepsis outcomes. The results of
this proposal will validate the importance of maintaining plasma SAA/SAA-HDL levels as one of the critical
parameters to be considered in developing any therapeutic strategy for this serious disease and developing SAA
memetic peptides as a therapeutic approach.

Public health relevance
Narrative Preliminary studies show that Serum Amyloid A (SAA) protects mice from sepsis-induced mortality. This proposal will investigate the mechanisms and pathways by which SAA is protective in sepsis. Results are expected to validate SAA-based peptides as therapeutics in sepsis, and aid in developing new biomarkers for identifying individuals at the highest risk for sepsis-induced mortality.